Defining the scope and clinical impact of donor CHIP after allogeneic HCT

PROJECT SUMMARY
Allogeneic hematopoietic stem cell transplantation (HSCT) involves the transfer of healthy donor hematopoietic
cells, including hematopoietic stem cells and mature immune effector cells, to recipients with high-risk
hematologic malignancies. The success of HSCT is fundamentally dependent on engraftment of normal donor-
derived hematopoiesis. Inadequate graft function can cause a range of complications that impact recipient
outcomes, including disease relapse, graft versus host disease, and infection. In preliminary studies, we
identified healthy stem cell donors with clonally restricted hematopoiesis, marked by mutations in canonical
genetic drivers of myeloid malignancies, where the aberrant clone engrafted in a transplant recipient, underwent
selective expansion, and was associated with abnormal hematopoietic function. While rare patients developed
donor cell leukemia after long latency, our data suggest that non-malignant outcomes of donor-engrafted clonal
hematopoiesis, such as hematopoietic dysfunction or graft versus host disease may be more common and may
manifest earlier after transplantation, thereby contributing significantly to transplant-related morbidity. We
hypothesize that the presence of clonal hematopoiesis of indeterminate potential (CHIP) is an age-independent
predictor of donor hematopoietic fitness that negatively impacts recipient outcome by causing impaired graft
function. This proposal combines complementary genetic, functional, and transcriptomic approaches in a large
cohort of stem cell donor-recipient pairs to define the impact of donor CHIP on allo HSCT outcomes. In Specific
Aim 1, we will determine the frequency and clinical significance of CHIP in a 1911 allogeneic stem cell donors
40 years of age and older (discovery cohort,n=1189; external validation cohort, n=722). To complete this aim,
we have developed and validated a highly sensitive sequencing platform for identification of CHIP in donor
samples, with >50-fold greater sensitivity than standard next generation sequencing modalities. This work will
be closely linked to Specific Aim 2, where we will focus on the subset of donors with clonal mutations to define
the efficiency and lineage potential of clonal stem cell engraftment, and the genetic evolution of clones over time.
Finally, in Specific Aim 3 we will dissect the functional impact of donor CHIP on immune function in transplant
recipients, testing the hypothesis that stem cell clones can perturb inflammatory cytokine production and proper
recovery of immune activity via their clonal contribution to mature immune cell subsets. Together, the proposed
studies may define a new paradigm of donor-attributable risk in allogeneic HSCT and provide insights into
biological mechanisms of clonal dominance and the influence of microenvironmental context on clonal evolution.

Public health relevance
PROJECT NARRATIVE Allogeneic hematopoietic stem cell transplantation (HSCT) is the only curative treatment for many high-risk blood cancers, but is associated with significant morbidity and mortality. This project will use state-of-the-art tools to identify and characterize the relationship between genetic changes in normal donor stem cells and development of post-HSCT complications in patients. Understanding this fundamental relationship, and their functional impact on donor immune cells, could lead to novel approaches to HSCT and improved outcomes.